Impact of IL-1 signaling on hematopoietic stem cell function and emergence of clonal hematopoiesis.

PROJECT SUMMARY
The long-term objective of this proposal is to identify mechanism(s) that promote clonal hematopoiesis of
indeterminate potential (CHIP). CHIP is a risk factor for cardiovascular disease, myeloid hematological
malignancy, and all-cause mortality. CHIP is thought to arise from mutant hematopoietic stem cells (HSC)
carrying oncogenic mutations that endow the cells with increased fitness, leading to expansion of the mutant
clone. Rare hematopoietic clones carrying CHIP-associated mutations are near-ubiquitous in healthy
individuals. However, CHIP is largely confined in older individuals or patients with a history of smoking, chemo-
or radiotherapy exposure. This suggests that physiological perturbation(s) unique to aging and genotoxin
exposure, such as chronic inflammation, are required to drive CHIP.
To better understand the mechanism underlying CHIP, we have conducted mouse studies that indicate chronic
IL-1 production in the BM is a common consequence of aging and exposure to radiation or chemotherapy. Our
preliminary data show that chronic IL-1 activates a cell growth arrest program associated with PU.1 induction in
long-term HSC (HSCLT). Strikingly, Tet2-deficient HSCLT fail to fully activate this growth arrest program during
IL-1 exposure. Along these lines, our data show that increased Tet2-deficient clonal expansion requires
chronic IL-1. These preliminary data suggest that clonal expansion of mutant HSC is an emergent feature
dependent on chronic inflammation.
The studies proposed here will identify and characterize the molecular and cellular mechanisms by which
chronic IL-1 promotes mutant HSC clonal expansion, using Tet2-deficiency as a model. Lines of investigation
will include molecular and cellular analyses of normal and Tet2-deficient HSC exposed to IL-1, and competitive
transplant assays to assess the functional impact of chronic IL-1 on normal and Tet2-deficient HSC fitness
side-by-side. Lastly, experiments will assess whether IL-1 blockade can restore normal HSC fitness and
reverse or limit clonal expansion. Altogether, our investigations could provide a basis for redefining CHIP as a
potentially reversible process of somatic evolution in which an inflammatory BM environment selects for mutant
HSC clones.

Public health relevance
PROJECT NARRATIVE Clonal hematopoiesis of indeterminate potential (CHIP) is characterized by selective expansion of hematopoietic clones carrying oncogenic mutations, and is a risk factor for cardiovascular disease, myeloid leukemia, and all- cause mortality. While nearly everyone has these mutant hematopoietic clones at a very low level, CHIP is restricted to individuals who are old or have prior exposure to chemo- or radiotherapy. We hypothesize that chronic inflammation occurring in these conditions promotes CHIP, and we will test 1) whether CHIP results from a failure of mutant HSC to activate a cell growth arrest program induced the pro-inflammatory cytokine IL-1, and 2) whether blocking IL-1 can restore normal HSC fitness and reverse or limit mutant HSC expansion.